The impact of the physical microenvironment on trophoblast function

The placenta is a critical organ that develops during pregnancy to allow the fetus to obtain nutrients and remove waste. The placenta acts as both a gatekeeper and an endocrine organ; two functions which are vital for a healthy pregnancy. However, how the placenta acts after perturbations of the system is not well known due to ethical concerns regarding obtaining tissue throughout all stages of pregnancy and poor in vitro or ex vivo systems that lack the level of control and physiological relevance needed. In preliminary studies, we have successfully made an in vitro microfluidic placenta model that allows for culture of three different cell types (trophoblast, fibroblasts, and endothelial cells) within natural protein gels. Microfluidic channels incorporate shear stress into the model and the tri-cell culture allows for cell-cell communication which have both been shown to be vital for physiologically relevant trophoblast phenotype. Cells can be cultured on natural substrates derived from human placenta with (1) ease, (2) in parallel, (3) with tight control, and (4) without the need for technical expertise in microfluidics. The model can easily be updated to study many mechanistic and fundamental properties of the healthy or dysregulated placenta. One disease that can cause complications during pregnancy, preeclampsia (PE), is associated with disrupted placentation from limited remodeling of the uterine wall; a process vital to ensure healthy placental tissue, proper oxygen concentration, and appropriate amount of shear stress within the placenta. Due to the lack of uterine remodeling, placental extracellular matrix (ECM) is stiffened via fibrosis, oxygen tension is lowered, and shear stress is increased. We hypothesize that these physical microenvironmental cues within the placenta cause disrupted trophoblast function that can be mechanistically examined in our novel microfluidic placenta model. In Aim 1 we will alter our microfluidic device in order to test how ECM dysregulation alters trophoblast function. We will make stromal layers of healthy or pathogenic stiffnesses from both collagen-I and human placenta derived ECM. Placental derived ECM will enable us to test how the full milieu of the placenta ECM impacts trophoblast function, while the collagen-I ECM will allow for tighter control of the environment. In Aim 2 we will test the closely tied relationship between oxygen tension and shear stress on trophoblast function. Devices will be cultured at healthy or pathogenic oxygen tension and shear stress to elucidate if their stimuli are synergistic. These studies will demonstrate the ease of our system in being able to control the microphysical properties of the system for elucidation of mechanistic properties of multi-cell models of the placenta.

Public health relevance
The placenta is a critical and necessary organ that when healthy supports fetal development but when diseased can induce health complications for both the mother and baby. There is a critical gap in knowledge as to how the dysfunctional placenta changes in disease and how these changes disrupt the endocrine and gate-keeper role it plays between the maternal and fetal systems. We will use an in vitro microfluidic model of the placenta to characterize how changes that occur in the disease preeclampsia effect the endocrine and barrier function of the placenta.